Translation and Integration of Genomics is Essential to Doctoral Nursing: "TIGER"

PROJECT SUMMARY/ABSTRACT Nurses represent the largest numbers of health care workers. As a critical component of the health care workforce, nurses must have a strong foundation in genomics. This is particularly true for faculty preparing the next generation of nurses to provide clinical care and conduct research. Advances in genomic science are redefining our understanding of health and illness, necessitating a concomitant shift in nursing education and 1 practice. A goal of the nursing profession, highlighted in the Institute of Medicine Future of Nursing report , is to increase the number of nurses with doctoral degrees to ensure that sufficient numbers of faculty are available to prepare the nursing labor force needed for delivery of health care services. Doctoral-prepared nurses with terminal degrees of DNP and PhD have opportunities to lead change in health care systems and transform care with the translation and integration of genomics in education, scholarship and practice. The purpose of this educational project is to improve the knowledge and skills of doctoral nurses in medical genomics. The need for the project was identified through a literature review and targeted needs assessment of nursing faculty and students. The project will commence with a half-day medical genomics course provided as a preconference at the American Association of Colleges of Nursing annual doctoral conference followed by monthly webinars and web conferencing sessions for the remainder of the year. The project will use the training-of-trainers model2 to disseminate information and strategies to implement genomics nursing education and is expected to prepare at least 200 additional trainers in medical genomics over the course of five years. These trainers will translate and integrate genomic information in nursing academics, scholarship and practice to serve as genomic champions at their schools of nursing. The primary aims of this proposed educational project are to: 1) develop and implement educational programs and materials aimed to achieve competency in medical genomics for doctoral nurses. 2) prepare doctoral nurses to integrate genetic and genomic content into academics and clinical practice; and 3) determine areas of strengths and weaknesses of doctoral nurses in foundational genomic concepts to inform future educational planning. The course offers didactic and experiential training as well as written and online resources, to facilitate the translation and integration of genomic content. Ongoing program evaluation will guide subsequent courses to address gaps in understanding and barriers to implementation. Doctoral nurses will obtain knowledge and skills to incorporate genomic medicine into academic curricula as well as in research and clinical practice. This educational program in medical genomics builds on the investigators' collective experience with educational endeavors in genomics and is an educational collaboration between the investigator/s and the American Association of Colleges of Nursing (AACN).

Public health relevance
PROJECT NARRATIVE The overall purpose of this national training program is to prepare doctoral nurses, including those with a Doctor of Nursing Practice (DNP) and/or a Philosophy Doctorate (PhD), to translate and integrate genetic and genomic content into doctoral nursing academic curricula, scholarship and practice. The foundations for this medical genomics educational training program include: Genomic Nursing Competency Implementation Strategic Plan 2014-20203, the Genomic Essential Genetic and Genomic Competencies for Nurses with Graduate Degrees4, and the Essentials of DNP Education5. The primary aims will be achieved through a half- day genomics course offered at an annual national doctoral nursing conference each January, followed by monthly webinars/web conferences through the remainder of the year to sustain interest, engage learners, and create a community of learners to become genomic nursing doctoral champions for their nursing school.